Understanding post translational modifiers in DNA damage repair

PROJECT SUMMARY/ABSTRACT
Our environment is replete with agents, such as high energy radiation, air pollutants, industrial chemicals,
pesticides, and heavy metals that can damage DNA and thus compromise genome stability. Among myriad
environmentally-induced DNA lesions, the DNA double-strand break (DSB) is possibly the most deleterious
because of its potential to induce chromosomal rearrangements and collapse of DNA replication forks.
Homologous Recombination (HR) is a conserved mechanism that eliminates DSBs in an error-free fashion, and
defects in HR are very mutagenic, and associated with premature aging, neurological disorders, and cancer. As
in other complex biological processes, HR is subject to regulatory controls being dependent on protein
phosphorylation-dephosphorylation. Of all known phosphorylation-dephosphorylation circuitries within the DNA
damage response (DDR), the kinases and phosphatases that act on tyrosine residues in target proteins remain
the most poorly defined. Importantly, we have found that the dual activity phosphatase EYA4 can
dephosphorylate physiologically relevant tyrosine residues on the DDR factors H2AX and RAD51. Accordingly,
depleting EYA4 sensitizes cells to ionizing radiation and genotoxic chemicals, and it also leads to severe
destabilization of the genome, causing chromosomal breakage and high levels of aneuploidy. Unexpectedly, our
biochemical analysis of highly purified EYA4 has shown that its protein phosphatase activity is dependent on
DNA addition and that EYA4 has intrinsic DNA binding activity. Moving forward, we will use a combination of
biochemistry, cell biology, and NMR to understand how the DNA binding activity of EYA4 contributes to its role
in DNA damage repair and genome protection, at DSBs and also DNA replication forks. Through these studies,
we will gain insight into a hitherto unknown circuitry of DDR protein phosphorylation-dephosphorylation that has
a major impact on the cellular response to environmental exposures.

Public health relevance
PROJECT NARRATIVE We focus on understanding how human cells repair DNA double strand breaks induced via environmental exposures and protect stressed replication forks against attrition mediated by nucleases. Specifically, we will elucidate the role of the dual specificity phosphatase EYA4 in genome repair and maintenance pathways. The results from our endeavors will help fill a major knowledge gap regarding cellular defense against the cytotoxic and genotoxic effects of environmental clastogens.